EXERCISE WITHIN A LOWER BODY NEGATIVE PRESSURE (LENP) CHAMBER

After exposure to simulated microgravity(bed rest),exercise capacity is reduced. Upright exercise is more effective than supine exercise in maintaining exercise capacity during bed rest. We hypothesize that application of LBNP during exercise may simulate the hemodynamic effects of the upright position and maintain exercise capacity during bed rest. This theory will be tested in 32 subjects during 5-day bed rest trials; group 1 = no exercise, group 2 = upright exercise, group 3 = supine exercise, group 4 = supine exercise against LBNP.